Role of White Matter Integrity in Age-Related Functional Reorganization

Project Summary/ Abstract The objectives of this Pathway to Independence Award (K99/R00) for Kristen Kennedy, Ph.D., are to expand the candidate's expertise in the field of cognitive neuroscience, to enable her to investigate novel questions regarding the role of white matter integrity in supporting age-related functional reorganization, and to transition successfully to an independent scientist in a tenure-track position at a research university. Combining structural and functional measures of brain integrity is a major goal in the field of the cognitive neuroscience of aging, and knowledge gained from this study should bring us closer to understanding how brain structure affects the brain's functional reorganization and the compensatory nature of that reorganization. The central aim of this project is to investigate the role of white matter structural connectivity in bilateral recruitment and to examine the compensatory nature of this functional reorganization. The hypotheses will be tested in a lifespan sample of adults using Diffusion Tensor Imaging, measures of cognitive performance, and a semantic judgment functional MRI task from which we can measure a bilateral activity index. The specific aims of this proposal are: 1) To test the hypothesis that white matter connectivity governs age-related bilateral recruitment; 2) To combine white matter integrity and cognitive performance to determine the compensatory nature of age-related bilateral recruitment; and 3) To experimentally manipulate task demands to test the hypothesis that white matter connectivity becomes more important in supporting bilateral recruitment as difficulty increases. Because the candidate's ultimate goal is to secure a tenure-track faculty position in a research-oriented university, award of this proposal will facilitate acquiring that position well-prepared for the transition from mentored to independent work and with the professional skills necessary to manage a neuroimaging lab. Lastly, award of this proposal will allow the candidate to prepare and submit a major research proposal (R01) at an earlier stage than would be possible without this K99/R00 mechanism.

Public health relevance
Project Narrative The present proposal seeks to provide new knowledge to the field of cognitive neuroscience of aging by examining brain structure and function in the same individuals to allow the study of one to inform understanding of the other. Combining these measures of brain integrity is a major goal in this field and knowledge gained from this study should bring us closer to understanding how brain structure affects the brain's function. Importantly, we are beginning to realize that the aging brain is more plastic and malleable to functional reorganization than previously believed and there is building evidence that this reorganization in older adults is invoked to support better cognitive performance. The goal of the present proposal is to further understand this promising process, and ultimately the functional reorganization patterns seen in older adults, once deemed beneficial, can be studied as a potential cognitive intervention for older adults to maintain good cognitive performance to develop training tasks that produce this pattern in lower-functioning older adults. Extending the cognitively healthy years toward the end of the lifespan would have significant public health implications. __SpecificAimsTextDelimiter__ II. RESEARCH PLAN A. Specific Aims The goal of this project is to understand the role of white matter integrity in supporting reorganization of neural activation during aging. Normal aging brings about detrimental changes in the integrity of the brain's structure and function, which mediates declines in cognitive abilities. With age, there are decreases in the quantity and quality of white matter, thinning of gray matter cortical gyri, and concomitant increase in the size of ventricles and sulci. Importantly, the very connections that allow communication and neural transmission across the brain are the same fibers that are so vulnerable to the aging process, which leads to disruption or "disconnection" of the cortical connections. Advanced age is also associated with functional reorganization of brain activity, whereby older brains typically show different patterns of neural recruitment that involve cortical regions not included in the activation patterns of younger adults. One common pattern of functional reorganization is the observation from several studies that older adults often recruit additional contralateral areas of the brain involved in processing higher-level information, namely association cortices such as dorsolateral prefrontal and posterior parietal ("bilateral recruitment"). Surprisingly, it remains largely unknown what brings about this functional reorganization, nor is it entirely clear whether this reorganization is beneficial to cognitive processing or is merely a byproduct of a less efficient brain suffering from reduced volume and cortical disconnection. To understand fully the complex patterns of cognitive aging and to determine the mechanisms underpinning those patterns, it is imperative to combine the study of both brain structure and brain function within the same sample. Specifically, because it is important to understand the interactions among anatomically distant brain regions, gauging white matter integrity along specific cerebral pathways is a natural approach to attaining this objective, and is the focus of this proposal. The bilateral recruitment observed in older adults may be compensatory for decreased structural connectivity or, alternatively, it may be that it is structural connectivity that allows the reorganized brain function to occur. These factors can be disentangled when studied in the context of connectivity and cognitive performance. Thus, the central aim of this proposal is to investigate the role of white matter structural connectivity in bilateral recruitment and to examine the compensatory nature of this functional reorganization. Our hypotheses will be tested in a lifespan sample of adults using Diffusion Tensor Imaging, measures of cognitive performance, and a semantic judgment functional MRI task that was chosen because we can measure a bilateral activity index in this task. The specific aims are as follows: A1. To test the hypothesis that white matter connectivity governs age-related bilateral recruitment. We take an individual differences approach, utilizing a large, lifespan sample of adults (aged 20-89). We will measure regional white matter integrity and a bilaterality index for each participant from prefrontal and posterior parietal regions. Hypothesis 1: Bilateral recruitment in the PFC and parietal cortex will increase with age and will be mediated by white matter integrity in the prefrontal-parietal connections and in the corpus callosum (CC) in the older but not younger adults (who have intact white matter). This specific aim will also examine the relative contributions of two key pathways in predicting bilateral recruitment: cross-hemispheric connectivity (via the CC) or association cortex networks (via the frontal-parietal pathway). Hypothesis 2: Fronto-parietal integrity will be more important for bilateral recruitment than CC integrity. This aim will also examine the relation between white matter structural integrity and functional connectivity. Hypothesis 3: Age- related decrements to fronto-parietal and CC white matter integrity will be associated with decreased functional connectivity between these association cortices. A2. To combine white matter integrity and cognitive performance to determine the compensatory nature of age-related bilateral recruitment. To examine the nature of bilateral recruitment across the lifespan we will compute three statistical path analysis models, for young middle and old age groups. In these models, for middle-aged and old adults, white matter integrity will directly predict both bilaterality and cognitive performance, and the bilaterality index will also predict cognitive performance. White matter integrity will have a weaker path for young adults and bilaterality may have a negative path for the young, as unilateral activations may actually be better predictors for young adults. Hypothesis 4: Bilateral recruitment in older adults is compensatory, as evidenced by increasing strength of associations across each age group. For example, early bilateral recruiters in middle age may have greater white matter integrity and cognitive performance. However, if there is no significant change in the associations over the agespan, then bilateral recruitment can be considered a byproduct of brain aging, with no compensatory function. At present no studies exist with the statistical power, research design, or sample size to test this important question. The combination of these three indices will help disentangle the nature of bilateral recruitment in older adults. A3. To experimentally manipulate task demands to test the hypothesis that white matter connectivity becomes more important in supporting bilateral recruitment as difficulty increases. Because the focus of the independent phase was on a lifespan study of individual differences in structure-function relations, the goals of the independent phase research are to examine the age effects on these structure-function associations when task demands are experimentally manipulated in groups of young and old adults. Specifically, this research will investigate whether the structure-function relations seen in the mentored phase change in response to increased task demands. If the prefrontal-parietal network is significantly degraded in older adults but is also the region called upon to increase in conditions of greater difficulty or mental control, then the brain should have to compensate accordingly. Therefore it would be expected that these structure- function associations would become stronger in the older age group in the more demanding conditions. Thus, for the independent phase, I propose three structure-function studies that each includes a difficulty manipulation to test this idea across tasks. It is hypothesized that, 1) regardless of the areas involved in task- related processing in the young, older adults will consistently (over)recruit the fronto-parietal network in the demanding conditions compared to the young. Further, I hypothesize 2) this degree of overactivation will be dependent on the integrity of the prefrontal-parietal white matter. In this sense, the goal of the independent phase is to test the broader notion that the prefrontal-parietal network (structure and function) serves as a general, task-independent compensatory mechanism that supports cognition in older adults across cognitive domains.